Molecular and Biochemical Basis of SMAD4 Mutation in Myhre Syndrome

Project Summary:
Myhre syndrome is an increasingly diagnosed rare disease that is caused by a heterozygous gain-of-function
pathogenic variant in SMAD4 at the codon for Ile500. As a connective tissue disorder, the core symptom of
Myhre syndrome is life-threatening progressive fibrosis in multiple organs. SMAD4 gene encodes a crucial
component of the TGF/BMP/SMAD signaling pathway that is involved in many cellular processes in both the
adult organism and the developing embryo. Mutations or deletions in the SMAD4 gene have been shown to
result in various disorders including hereditary diseases and cancers. Intriguingly, Myhre syndrome is only
associated with the missense mutations at Ile500 in SMAD4. The invariant location and restricted spectrum of
Myhre syndrome-causative mutations support the hypothesis that alteration in Ile500 has distinct and specific
consequences on SMAD4 function, resulting in Myhre syndrome.
Like many other rare diseases, Myhre syndrome remains significantly understudied. Particularly, there is no
available treatment for this disease due to a poor in-depth understanding of the mechanism by which the
SMAD4 mutation acts. In this proposal, we will capitalize on our recently developed Myhre syndrome mouse
model to test a hypothesis that SMAD4 mutation at Ile500 alters its structural and functional integrity,
contributing to the increased SMAD4 protein level, enhanced SMAD4 transcriptional activity, and rewired
intermolecular interaction. In SA1, we will examine if SMAD4-Ile500 mutation exhibits an intrinsic effect on its
protein stability. To this end, we will quantify the relative protein level of SMAD4, regulatory SMADs, and their
phosphorylated status in newborn mice before the disease manifestation. Multiple organs that are
developmentally derived from 3 germ layers will be examined. In SA2, we will interrogate if SMAD4-Ile500
mutation enhances SMAD4 transcriptional activity and rewires its intermolecular interaction. According to the
crystal structure of SMAD4, Ile500 is close to the protein surface. The solvent-exposed location of this region
and its highly charged character make it a likely candidate for protein-protein interactions. In addition, Ile is
adjacent to the SMAD4 activation domain. We will use skin fibroblasts as a proof-of-function cellular system to
measure SMAD signaling transcriptional activity (luciferase assay, transcriptomic profiling) and to map SMAD4
interactome by Affinity Purification-Mass Spectrometry (AP-MS).
This work will provide initial experimental data to develop a plausible mechanism of the causal role of SMAD4
mutation in Myhre syndrome disease, a key for expediting the development of novel therapeutic interventions
for disease progression.

Public health relevance
Project Narrative: Myhre syndrome is a rare, recently characterized genetic disorder exhibiting progressive and proliferative systemic fibrosis. Although SMAD4-I500 mutation is a causal factor for Myhre Syndrome, little is known about the mechanism by which this mutation acts and how it leads to the disease. Here, we will examine if the SMAD4 mutation at Ile500 alters its structural and functional integrity, contributing to the increased SMAD4 protein level, enhanced SMAD4 transcriptional activity, and rewired intermolecular interaction.